Core 2 Biospecimen/Pathology Core

The goal of Michigan Prostate SPORE Biospecimen/Pathology Core is to collect biological materials with
associated clinical information to facilitate translational prostate cancer research. The Core places patient
confidentiality and clinical care as a top priority. As a coordinated effort between pathology, urology, medical
oncology, radiation oncology, and Michigan Prostate SPORE researchers, the Core has developed a unified
informatics infrastructure that provides researchers a wide range of annotated samples. The specific goals of
the Core include: (1) Protection of patient welfare. The highest priority is given to assure that no research protocol
compromises pathology diagnosis or tumor staging. (2) Acquisition and processing of prostate tissues for
research. The Core assures that the widest range of prostate tissues and derived biomolecules are available
from various sources, including benign prostate tissue from patients without any known prostatic disease,
clinically localized prostate cancer, and metastatic hormone refractory prostate cancer (Michigan Legacy Tissue
Program). (3) High quality pathologic review of prostate tissues. Expert GU pathologists assure uniform review
of prostate tissue samples. (4) Pathology consultation for the purpose of designing translational research
projects. This service focuses on determining the types of tissues and amount required for the successful
completion of the research projects. (5) Quality assessment of prostate tissues and clinical data. The
Biospecimen/Pathology Core staff regularly evaluates frozen and formalin fixed tissues for adequacy. (6)
Development of technology appropriate for pathology-based translational research. New technologies such as
integrative high-throughput sequencing, RNA in situ hybridization, and single-cell analysis have been introduced.
(7) Provide support to ongoing clinical studies. The Core will continue to provide tissue procurement services
and/or high-quality pathology reviews of specimens from patients enrolled in various clinical trials and studies.
(8) Maintenance of clinical and pathology data with links to molecular studies. The Core will continue to expand
the detailed clinical and pathology database conforming to the NCI's Common Data Elements (CDE) guidelines,
permitting queries between molecular findings and clinically relevant outcomes. In summary, the Core will
provide SPORE investigators with a wealth of carefully annotated samples for translational research, while
maintaining the highest level of clinical care and patient confidentiality.

Public health relevance
The Michigan Prostate SPORE Biospecmen / Pathology Core collects, annotates, and stores critical prostate cancer related biospecimens required for patient-oriented research. It also has the capabilities for the morphological analysis of tissues and molecular analysis of tissues and biofluids. Our continued goal is to decrease the morbidity and mortality of prostate cancer through innovative research that is supported by biospecimen resources, database and informatics support.